SAFETY AND TOLERANCE OF HIGH VERSUS LOW DOSE ZIDOVUDINE IN CHILDREN

This study is designed to determine whether there are differences in tolerance and side effects associated with two dosing schedules of ZDV when used to treat HIV-infected children.